Triangulating Mechanisms of Microbiome-Joint Crosstalk

7. PROJECT SUMMARY
The proposed work focuses on interorgan communication between the gut microbiome and the joint in the
pathogenesis of osteoarthritis (OA). Although historically viewed as a disease caused by mechanical overload,
recent studies indicate that systemic factors are a major contributor to OA. The gut microbiome is a critical
regulator of systemic inflammation and is readily modified in individuals, making it an enticing therapeutic
target. Studies by our group and others indicate that the gut microbiome is a potent regulator of OA capable of
enhancing or blunting trauma-induced osteoarthritis in animal models. Aging is associated with alterations in
the composition of the gut microbiota, increased systemic inflammation and increased susceptibility to OA. In
several cases, age-related changes in the gut microbiome are major contributors to disease. However, it is not
known if the gut microbiome influences spontaneous age-related osteoarthritis, nor is it clear if age-related
changes in OA are due to age-related changes in host physiology or age-related changes in the gut microbiota.
Clinical and preclinical studies have implicated microbially-derived molecules that transit from the gut into the
systemic circulation as regulators of the relationship between the gut microbiome and the joint. However, the
association between microbiome-induced changes in musculoskeletal tissues and microbially-derived
metabolites is currently limited to examination of fecal samples. Supported by robust PRELIMINARY STUDIES
suggesting an effect of the gut microbiome on age-related OA and implicating key microbiota-dependent
metabolites with severity of OA, we propose the global hypothesis that the gut microbiota regulates the effects
of aging on joint degeneration. Specifically, we ask: Does the microbiome influence spontaneous, age-related
joint degeneration? To what degree do age-related changes in the gut microbiota v. age-related changes in
host physiology promote joint degeneration? Which of the circulating microbiota-dependent molecules link the
gut microbiome to joint degeneration? How do these effects differ by sex? The proposed work has three aims
explored using mouse models: 1) Determine the effects of the gut microbiome on age-related spontaneous
osteoarthritis; 2) Determine the contribution of age-related changes in the gut microbiota to osteoarthritis; and
3) Determine the role of circulating microbiome-derived metabolites on the severity of osteoarthritis. At the
completion of the proposed work, we will have addressed key interactions between the gut microbiome and
aging in the context of joint degeneration and determined the effects of microbiota-derived molecules as
signaling factors linking the gut microbiome to OA.

Public health relevance
8. PROJECT NARRATIVE The long term goal of this work is to prevent age-related osteoarthritis. In this project we examine how the gut microbiome influences osteoarthritis, focusing on molecules released by the gut microbiome. The work has the potential to lead to new treatments to prevent osteoarthritis.